Vendor Audit Support Through the Comprehensive and Rapid Response to NIAID Research Programs (CARRRP) Contract

Quality assurance audits of the activities performed under the DMID Clinical Research Operations and Management Support (CROMS) contract in compliance with ICH Good Clinical Practice (GCP) and applicable federal regulations.